Cytomegalovirus manipulation of functional cortical tissue development

PROJECT SUMMARY
Human cytomegalovirus (HCMV) infects much of the world’s population and establishes a life-long persistent
infection defined by both lytic and latent states, and HCMV continues to be a significant issue in human health.
HCMV is the leading cause of non-heritable birth defects in the United States and likely around the world. If the
virus crosses the placental barrier, HCMV replicates in developing neural tissues resulting in significant
neurodevelopmental consequences and central nervous system damage. Several antiviral treatments exist but
are not approved for use during pregnancy due to toxicity and potential teratogenic effects. Our collaborative
project aims to address the significant deficiencies in understanding the underlying neural pathogenesis of
congenital HCMV infection in human neural tissues and the lack of antiviral approaches. In this regard, we have
found that HCMV infection induces significant downregulation of key neurodevelopmental transcripts and
pathways and leads to substantial disruption of structural organization, differentiation potential, and calcium and
electrophysiological function in human induced pluripotent stem cell (iPSC)-derived neural progenitor cells
(NPCs) and 3-dimentional cortical organoids. Interestingly, we further discovered that these pathologies were
not dependent on full viral replication and that standard antiviral approaches were insufficient to restore normal
human brain cell development and function. Moreover, the production of nitric oxide as an innate immune
response to limit viral replication was overtly detrimental to cortical organoid tissue structure and NPC
differentiation potential. Therefore, we will expand on these data to (1) define the transcriptional and cellular
disruptions to developing human neural cells by HCMV infection, (2) determine the impact of specific viral
proteins in disrupting human brain development, and (3) elucidate the non-cell autonomous influence of HCMV
infected microglia on human brain development. These aims are based on our significant amount of published
and preliminary data that sets the foundation for the proposed experiments. We will use bulk, single cell, and
spatial transcriptomic technologies, calcium imaging, microelectrode array, and sophisticated microglia-cortical
organoid iPSC culturing and analysis approaches to better elucidate the viral and cellular mechanisms
contributing to the neurodevelopmental impact of HCMV infection. Congenital HCMV infection can have
devastating effects on children, pose significant challenges for parents and caregivers, and continues to be a
significant world health problem. The collaborative team is uniquely qualified to carry out these highly novel and
impactful studies that will uncover fundamental aspects of HCMV infection in human brain tissues with the
ultimate goal of aiding the development of appropriate, targeted, and effective therapeutic interventions.

Public health relevance
PROJECT NARRATIVE The human herpesvirus, cytomegalovirus (HCMV), infects much of the world’s population and is a leading cause of congenital birth defects impacting early brain development. Our goal is to uncover the direct and indirect mechanisms whereby HCMV proteins manipulate cellular processes to promote infection and impede neurodevelopment and neural function. Defining the landscape of molecular events that occur during infection will enhance our understanding of the biological and cellular consequences of infection and facilitate the development of new antiviral and neurotrophic strategies to manage HCMV infection.